Human neuropeptide transmitter systems are dysregulated in Alzheimer's disease pathogenesis

Project Summary
Diverse brain neuropeptides, known as neuropeptidomes, comprise the majority of neurotransmitters that
are essential for modulating Alzheimer’s disease (AD) deficits in dementia. The gap in the field is that global,
unbiased neuropeptidomics analysis of the repertoire of human brain neuropeptides has not yet been achieved,
nor have the human brain proteases that produce neuropeptides from their precursors been experimentally
identified. Therefore, this project will close this gap by defining human brain neuropeptidomes and their
biosynthetic proteases in normal and AD conditions. In support of this research, our group conducted a pilot
study that demonstrates dysregulation of synaptic neuropeptidomes in human Alzheimer’s disease (AD) brain
cortex compared to age-matched controls, involving proteolytic mechanisms. Furthermore, to identify proteases
utilized to synthesize neuropeptidome components, we developed a multi-omics approach which integrates
neuropeptidomics, protease cleavage profiling, and proteomics. Given that human-specific mechanisms for
neuropeptide production may exist, studies of human brain neuropeptidomes are necessary to understand
neurotransmitter regulation in normal human brain and in human AD brain.
The goals of this project will be to, firstly, elucidate the full repertoire of neuropeptidome signatures and their
biosynthetic proteases in normal human brain hippocampus and cortex subregions that participate in memory
functions, combined with the hypothalamus that regulates metabolism and stress. Secondly, human brain
regions from AD and the pre-AD stage of mild cognitive impairment (MCI) will be assessed for dysregulation of
neuropeptidomes and biosynthetic proteases compared to age-matched controls. Dysregulated neuropeptides,
including the chromogranins and VGF, will be assessed for regulating neuronal activities and toxicities.
We will assess the hypothesis that synaptic neuropeptidomes are dysregulated in human AD brain, and that
they possess biological activities for regulating neuronal functions. The specific aims will (1) study normal human
brain regions involved in memory function to define neuropeptidomes and their biosynthetic proteases by multi-
omics strategies, (2) evaluate protease production of human neuropeptidomes in young to older ages of human
induced neurons (iNs), (3) investigate human AD and MCI brains for dysregulated synaptic neuropeptidomes
and their biosynthetic proteases compared to controls, and (4) conduct functional analysis of AD dysregulated
neuropeptides for regulating neuronal electrical network activity, metabolism, inflammation, cell death, and
molecular pathways of cellular functions in human sporadic AD, MCI, and age-matched iNs.
Significant findings will discover normal brain neuropeptides and their biosynthetic protease mechanisms,
and, importantly, provide new knowledge of dysregulated human brain AD neuropeptidomes that regulate
neuronal deficits related to AD. Such neuropeptides may represent novel AD biomarkers, and biosynthetic
proteases may represent new drug targets for future AD drug discovery.

Public health relevance
Narrative Alzheimer’s disease involves synaptic deficits of neurotransmitters that are essential for brain functions, but comprehensive evaluation of the full repertoire of human brain neuropeptide transmitters (neuropeptidome) and their biosynthetic proteases has not yet been achieved in the field. Therefore, the goals of this project are, firstly, to elucidate normal human brain for neuropeptidome components and their biosynthetic proteases and, secondly, to elucidate human AD brain dysregulated neuropeptidomes and understand their roles in regulating neuronal functions including neurotoxicities. Findings from this research will advance knowledge of dysregulated neuropeptides that may represent novel AD biomarkers, and neuropeptide biosynthetic proteases as novel drug targets.